Environmental Exposures & Sleep in the Nurses' Health Study 3

PROJECT SUMMARY
The goal of this F31 fellowship application is to support and promote the training of Cindy R. Hu, currently a
pre-doctoral student in the Department of Environmental Health of the Harvard TH Chan School of Public Health
and the Graduate School of Arts and Sciences at Harvard University. Her long-term research interests focus on
the associations of multiple environmental exposures on sleep. Ms. Hu has assembled a group of leading
experts as her Sponsors and Co-Sponsors including Drs. Jaime Hart, Brent Coull, Peter James, and Susan
Redline. Sleep is an important component of human health; it is a process that serves key functions in cognition,
performance, physiological repair, and recovery. Inadequate sleep has been linked to many physical health
outcomes like cardiovascular disease, diabetes, and obesity, as well as mental health outcomes such as anxiety
and depression. A nation-wide analysis showed an uneven geographic distribution of insufficient sleep across
the US; this geographic variability may be explained by a confluence of social and environmental determinants
of health. Environmental exposures that shape one’s sleeping environment as well as exposures that are
experienced during wake can impact sleep health. Of particular interest due to their modifiability are built
environment factors, such as light at night, neighborhood greenspace, and walkability have been shown to
affect sleep. Currently, environmental epidemiological studies of sleep often rely on self-reported measures of
sleep. The development of mobile health technologies provides an opportunity to quantitatively measure sleep
in ecologically valid and free-living (i.e. non-laboratory) conditions on a larger scale, but requires validation
against research standards. In addition to quantitative assessments of sleep, mobile health data can provide
rich information on GPS location and behaviors like physical activity, which allow for investigation of
mechanisms that link environmental exposures to sleep. Another key aspect of furthering our understanding of
how the environment impacts sleep is the utilization of an exposomic framework; to our knowledge, no study
has examined the effects of multiple exposures on sleep. Using the unique resources of the Nurses’ Health
Study 3 (NHS3) longitudinal cohort, Ms. Hu will receive extensive training in multiple aspects of exploring the
impacts of the environment on sleep, ranging from how to compare objective measures from multiple sources
(Aim 1), using mobile health panel studies to examine associations between features of the built environment
on sleep outcomes (Aim 2), and how to scale these insights to a full cohort of US women and men (Aim 3). This
will position her to be a future leader in the field of the environment and sleep through high-quality mentorship
and extensive professional development opportunities.

Public health relevance
PROJECT NARRATIVE Sleep is a key process in the maintenance of health; suboptimal sleep contributes to health burden through increased risk for a range of mental health, metabolic, and chronic health outcomes. Environmental exposures, such as air pollution, greenness, and light-at-night, are linked to sleep; due to their ubiquity, modifiable environmental exposures that affect sleep are integral to the promotion of sleep health on a population level. This research aims to address gaps in various aspects of environmental health research on sleep by validating extant mobile health measurement tools for sleep, assessing a possible mediating pathway between an environmental exposure and sleep, and investigating the relationships between multiple environmental exposures and sleep independently and in an exposomic framework.